Molecular and functional implications of thalamo-striatal synapse regulation in learning and memory

PROJECT ABSTRACT
Cognitive changes occur as a normal process of aging and among the most important changes in cognition in
normal aging are declines in cognitive flexibility (CF). CF is considered a core aspect of executive functioning
and describes an individual’s ability to adapt their behavior and thinking to a changing environment.
Disruptions in CF impact functional independence, communication with others, and socialization. Despite the
well-documented prevalence of CF decline in aging, and its exacerbation in neurodegeneration, the
mechanisms that lead to structural and functional changes involved in the regulation of CF are not well
understood. The majority of studies related to CF impairment have focused on changes within the
hippocampus and cortex, however, the dorsal striatum, particularly the dorsomedial striatum (DMS), has long
been strongly associated with CF. The dorsal striatum is traditionally associated with control of motor function,
but recent human fMRI and PET analyses demonstrated that declines in striatal function predict declining
cognitive abilities during aging. Striatal function is governed by the innervation of two excitatory glutamatergic
circuits: cortico- (C-S) and thalamo-striatal (T-S). Importantly, T-S synapse density preferentially declines
during aging and is associated with declining CF performance. However, the regulatory mechanisms by which
T-S synapses are preferentially lost in the aging striatum and how they contribute to CF decline is unknown.
Depletion of the heat shock transcription factor 1 (HSF1), a transcription factor canonically known for its role in
cellular stress responses, within the striatum, accelerates T-S synapse loss and results in impairment of CF.
HSF1 levels also decrease in aging and HSF1 has been shown to directly regulate the transcription of synaptic
genes within the striatum and other brain regions. Taken together, the goal of this proposal is: 1) to determine
the molecular underpinning that govern the differential effects of HSF1-mediated synaptic regulation within the
DMS and 2) to understand the role of HSF1 and T-S synapses in striatal dysfunction and CF impairment. I
will fill these gaps in knowledge through two complementary aims. In Aim 1, I will examine the role of HSF1 in
the regulation of the synaptoproteome of excitatory striatal projections through proteomic analyses of T-S and
C-S synaptic terminals and synapses from a conditional HSF1 knock-out mouse. In Aim 2, I will assess the
contribution of striatal HSF1 to CF by deleting HSF1 within the adult DMS using AAVs expressing Cre-
recombinase and the necessity of T-S connectivity to CF by optostimulation of T-S terminals in DMS.
Successful completion of this proposal will provide a mechanistic understanding of how synaptic dysfunction
within the DMS contributes to CF which has implications in aging and neurodegeneration, as well as establish
the role of HSF1 in the regulation of striatal glutamatergic synapses and CF that may result in new therapeutic
strategies to prevent CF deficits in the aging population.

Public health relevance
PROJECT NARRATIVE Declining cognitive flexibility is a debilitating symptom of aging and several neurodegenerative diseases that affects individuals’ independence, socialization, and ability to adapt to the changing world around them, placing the burden of care on loved ones, caregivers, and medical professionals. Despite its prevalence, there are currently no prevention or therapeutic strategies for treating impairments in cognitive flexibilities. I propose that a mechanistic understanding of the neural circuits governing cognitive flexibility and a molecular model describing the structural regulation of these circuits may result in the discovery of new therapeutic strategies to ensure independence in our aging population.